Background Oriented Schlieren (BOS) Visualization for Evaluation of Risk in Aerosol-Generating Procedures

Project Summary
Aerosol-generating procedures (AGPs) are medical procedures that produce aerosols that can be laden with
pathogens if the patient has a viral infection, such as SARS-CoV-2 or inﬂuenza. These aerosols pose a signiﬁcant
risk to health care workers, as they can linger in the air for extended periods of time and are small enough to
bypass ordinary surgical masks. There is currently no established, unambiguous way to evaluate the risks to
healthcare workers associated with a speciﬁc AGP, nor is there a rigorous method by which to assess a proposed
risk-mitigation strategy. To address this gap, a ﬂow visualization technique must be developed that can be applied
in a clinical setting during actual medical procedures and is capable of detecting aerosol-laden ﬂows produced
by AGPs or potential AGPs.
In this R21 proposal, we will adapt background-oriented schlieren (BOS) visualization, a method from ﬂuid
mechanics, into a technique that can be applied to study ﬂows produced by AGPs. The R21 project is high
risk with no published preliminary data, but the PIs have successfully demonstrated visualziation of aerosols
produced by jet ventilation, a speciﬁc type of AGP, using BOS in a proof-of-concept experiment. The proposed
work is signiﬁcant and timely, as assessment of the risk associated with AGPs is extremely important in the
context of the COVID-19 pandemic. We will use the novel BOS technique to assess risks and evaluate mitigation
strategies for three speciﬁc AGPs in both ex vivo and in vivo conditions.
Speciﬁc Aim 1: Develop a human-scale BOS system and establish a procedure for evaluating the risk
of AGPs in a clinical setting.
Speciﬁc Aim 2: Quantify the risk of aerosol exposure under different simulated and in-vivo conditions,
and identify strategies to mitigate the risks.
The signiﬁcance and impact of the proposed research will be in developing a tool for unambiguously evaluat-
ing the risks associated with AGPs in realistic clinical settings, and urgently-needed risk assessments for three
speciﬁc AGPs and experimentally veriﬁed risk mitigation strategies for each.

Public health relevance
Project Narrative Aerosol-generating procedures are medical procedures that can potentially produce pathogen-laden aerosols that pose a risk to healthcare providers. This has become a signiﬁcant issue as a result of the COVID-19 pandemic, but it is crucial that the risks associated with speciﬁc procedures can be evaluated in a rigorous way not just for the current pandemic but for any future disease outbreaks as well. New tools are needed to assess these risks and develop mitigation strategies, and the primary focus of this exploratory project is to develop such a tool and use it to evaluate risk for several key procedures.